Research Training in Women's Health and Intersectionality Using Data Science and Health Information Technology (WISDOM)

Enter the text here that is the new abstract information for your application. This section must be no longer
than 30 lines of text.
Revised WISDOM T32 Grant Sections
PROJECT SUMMARY/ABSTRACT (Revised)
The purpose of this T32 program is to prepare nurse scientists who have knowledge and skills to employ data
science (DS) and/or health information technologies (HIT) in order to advance health research using innovative
methodological approaches. This training will build on the strengths of the Emory University Nell Hodgson
Woodruff School of Nursing's currently funded research studies, faculty expertise, and supporting
infrastructure. It will address health research questions with a methodological focus on DS and HIT
applications. Trainees will develop knowledge and skills in interdisciplinary research methods, understand and
apply DS and/or HIT methodologies, and develop and test interventions using these innovative approaches in
health research.
The program comprises: 1) specific courses related to DS and HIT methodologies; 2) electives to individualize
training, develop an area of specialization, and facilitate trainees in interdisciplinary courses; 3) biweekly T32
seminars to foster trainees' integration of course content with other program experiences; 4) 15 hours a week
of work on faculty research over several semesters; 5) at least one semester of individualized research
practicum with center internships; and 6) participation in an interdisciplinary center on campus that relates to
the trainee's research area. Fifteen nurse scientists will be trained over 5 years. The program will engage 17
mentors and 6 interdisciplinary co-mentors. Over 10 research centers/institutes/departments have agreed to
collaborate, making this a fully interdisciplinary training program focused on advancing methodological
expertise in nursing science through innovative data science and health information technology approaches.

Public health relevance
PROJECT NARRATIVE (Revised) Advances in data science and health information technology offer unprecedented opportunities to enhance research effectiveness and improve health outcomes through innovative methodological approaches. The use of data science and health information technology will improve research effectiveness by providing various strategies that were not possible without these methodologies (e.g., increasing access to populations, improving the precision of measurements, enabling real-time data collection and analysis). The proposed T32 program trains pre-doctoral and post-doctoral nursing scientists within interdisciplinary teams to have knowledge and skills to employ data science and/or health information technology methodologies to advance nursing science and improve health outcomes through rigorous, innovative research approaches.